TASK ORDER 6: SUPPORT FOR THE INTERNATIONAL PERSPECTIVES ON INTEGRATIVE MEDICINE FOR CANCER PREVENTION AND CANCER PATIENT MANAGEMENT 2020 CONFERENCE

SUPPORT FOR THE INTERNATIONAL PERSPECTIVES ON INTEGRATIVE MEDICINE FOR CANCER PREVENTION AND CANCER PATIENT MANAGEMENT 2020 CONFERENCE